COVID-19, heavy drinking and alcohol use disorders: a national study of Veterans Administration patients

Coronavirus Disease 2019 (COVID-19) caused by SARS-CoV-2 is a global pandemic. While most COVID-19
cases are mild or moderate, severe cases (~15%) require hospitalization, critical cases (~5%) require intensive
care, and many deaths occur. Males, Blacks and Hispanics are at greater risk for COVID-19 infection, and poor
prognosis is predicted by older age, race/ethnicity, and prior underlying medical conditions. A potentially critical
factor not yet studied is heavy alcohol use or alcohol use disorder (AU/AUD). AU/AUD could increase the risk
for COVID-19 infection and poor prognosis through poor health behaviors, by direct effects of alcohol on the
immune system, or by indirect effects due to the greater prevalence of underlying medical conditions that predict
poor COVID-19 prognosis. Little is known about the relationship of AU/AUD to the likelihood of COVID-19
vaccination, infection, or poor prognosis, and if these relationships are modified by medical conditions (e.g.,
hypertension, obesity, diabetes), spatially-defined socioenvironmental or exposure variables (e.g., county
poverty or COVID-19 rates) or demographic characteristics (sex, age, race/ethnicity, poverty). To study this,
large databases are needed that include AU/AUD, demographic characteristics, spatial identifiers, diagnostic,
treatment and mortality information. Responding to PA-20-195 (and addressing issues in NOT-AA-20-011), we
will utilize the Veterans Administration (VA) Electronic Medical Record (EMR) system for this purpose. The VA
treats 6.3 million veterans a year. VA patients have high rates of COVID-19 vulnerability factors, e.g., male, older
age, chronic medical conditions. A VA Shared Data Resource identifies COVID-19 cases (now N=186,174, with
9,299 deaths). The many VA patients with ICD-10-CM AUD or positive alcohol (AUDIT-C) screens provide
extensive data on whether the likelihood of COVID-19 outcomes differ by AU/AUD status. Leveraging a research
infrastructure established in an existing project, we propose a 2-year study to comprehensively address the
relationship of AU/AUD to COVID-19 vaccination, infection and prognosis, and how these relationships are
affected by demographic, medical, spatial exposure characteristics. Aim1: Determine the relationship of AU/AUD
to COVID-19 vaccination, infection, and in those infected, poor prognosis (e.g., hospitalization, ICU treatment,
death). Aim 2: Determine if associations of AU/AUD with COVID-19 outcomes vary over time, medical conditions
(e.g., hypertension, obesity, diabetes), spatial exposures or demographic characteristics. In Year 01, we will
analyze EMR diagnostic, treatment, and vital status death data, using a 12-month lookback period to determine
AU/AUD and medical conditions that preceded COVID-19 outcome variables. In Year 02, we will incorporate
National Death Index data to examine causes of death, and expand information on veterans ≥age 65 with
Medicare data. Logistic regression will evaluate differences in COVID-19 outcomes by AU/AUD status. Among
those with COVID-19, survival models will determine if time to poor prognosis events differs by AU/AUD. Results
will fill major gaps in knowledge about the risks for and prognosis of COVID-19 among those with AU/AUD.

Public health relevance
This project will utilize the “big data” resources of the Veterans Administration electronic medical record system on over 6.3 million patients to help fill a major gap in knowledge about the likelihood of COVID-19 vaccination, infection and poor prognosis among individuals with heavy alcohol use /alcohol use disorder (AU/AUD). Findings can generate hypotheses about biological mechanisms of effect, help educate patients, providers, and service planners for the Veterans Administration and other patient groups with high rates of vulnerability factors, and can help educate the general public, especially those using alcohol to cope during times of stress and mass disaster. Finally, findings will better prepare scientists and clinicians for possible ongoing waves of COVID-19, and the challenges of additional novel coronaviruses with severe outcomes that may emerge in the future.